Optimizing Aerobic Fitness and Functional Response to Exercise in Older Adults.

PROJECT SUMMARY
Clinical events and hospitalization can be physically disabling, especially for older adults because of their
reduced physiological reserve. Cardiovascular disease (CVD) is the leading cause of hospital-acquired
disability in older adults, and many patients fail to remediate losses in physical functional capacity. To correct
these disabling effects, cardiac rehabilitation (CR) was established with exercise training as its foundation.
Moderate intensity continuous aerobic training (MICT) and moderate intensity resistance training (MIRT) are
core components of CR designed to improve functional capacity, with peak oxygen uptake (VO2peak) the
primary metric used to gauge its effectiveness. Despite clear functional and survival benefits of MICT+MIRT
training, some groups of patients who enroll in CR receive less functional benefit. Attention has focused on
high intensity interval aerobic training (HIIT) as an alternative intervention because it yields greater
improvements in VO2peak compared to MICT. However, neither of these aerobic training protocols address
skeletal muscle size and weakness that occur with aging, are exacerbated by hospitalization and limit exercise-
induced physical functional gains in older adults. While guidelines include MIRT in standard CR exercise
programs, it has minimal effects to remediate fundamental deficits in muscle size and contractility in older
adults. Thus, there is an unmet clinical need for innovative, multi-modal exercise interventions to optimize
gains in VO2peak and physical function with CR exercise that address specific limitations found in older adult
patients. Building on our strong published and preliminary data, the current proposal addresses this need by
testing the efficacy of combined HIIT+ high intensity resistance training (HIRT) to improve VO2peak and physical
function in patients eligible for CR compared to standard of care MICT+MIRT. We hypothesize that HIIT+HIRT
will promote greater functional improvements due to greater gains in skeletal muscle fiber size and function. To
test this hypothesis, we will evaluate patients eligible for CR using a rigorous, RCT design, with a sub-set of
patients undergoing assessments to examine the effects of each training program at the organ, tissue, and
cellular levels to define mediators of the benefits of exercise on functional capacity. Successful completion of
the proposed studies would challenge current clinical practice and advance a novel multi-modal CR exercise
paradigm to optimize improvement in VO2peak, physical function and clinical outcomes in older adults and
generate foundational knowledge of the mechanisms whereby these exercise modalities modulate function
capacity. Demonstration of the efficacy of HIIT+HIRT within CR, the largest, structured clinical rehabilitation
program that serves older adults, would provide a strong impetus to broaden the use of high intensity exercise
paradigms among healthy, older adults and patient populations.

Public health relevance
PROJECT NARRATIVE Hospitalization and treatment for cardiovascular disease is one of the main contributors to disability in older adults. Moderate intensity continuous aerobic and resistance training have been the cornerstone of cardiac rehabilitation (CR) for decades to remediate hospital-acquired functional deficits, but some groups receive less or minimal functional benefit from this training. The proposed studies seek to optimize recovery of aerobic fitness and physical function among older cardiac patients using a novel high intensity training regimen with the long-term goal of reducing subsequent disability and improving clinical outcomes.